DISSEMINATION; USER EDUCATION ACROSS A BROAD RANGE OF AUDIENCES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To be effective, education must target a very broad range of audiences, spanning communities with and without scientific expertise, with and without experience in applying complex scientific codes, and with and without experience in developing complex scientific codes. Such breadth makes effective dissemination particularly challenging, and this is true across all of Computational Biology in general. Our continuing dissemination plans target our entire audience through dramatically expanded and integrated teaching materials;teaching materials implemented with web-based tools that enable streamlined presentation and easy navigation even when the amount and complexity of content is substantial.